Translation of the Aging and Immunity Multiome (TAIM): a Pilot Lifestyle Investigation in WTC Exposed FDNY Responders

SUMMARY
The World Trade Center (WTC) attacks on September 11, 2001, exposed first-responders to toxic particulate
matter (PM) resulting in morbidity and disability. Accelerated aging due to environmental and nutritional exposure
is an area of investigation of global significance and pertinent to our WTC-exposed cohorts. We have identified
that metabolic syndrome was a risk factor of worsening lung disease, and implemented a successful
multidisciplinary dietary randomized clinical trial; Food Intake REstriction for Health OUtcome Support and
Education (FIREHOUSE). Subjects that lost weight had improved lung function and respiratory quality of life
symptoms. We have assayed their gut microbiome, metabolomics, and inflammatory profile, and collected
genetic samples. However, the mechanisms that link WTC-PM exposure, metabolism, aging, hyper-inflammation
and WTC-PM related lung disease are yet to be identified. We will focus on innovative concepts linking aging
and increased autoantibodies under the hypothesis that both processes can cause persistent hyper-inflammatory
states contributing to worsening lung function. We further hypothesize that: i. A nutritional lifestyle intervention
can modify aging and autoantibody biosignatures in a WTC-PM exposed cohort. ii. WTC-PM exposure induced
chronic inflammation and metabolic markers will be exacerbated by metabolic syndrome, age and transient
depletion of a key anti-inflammatory mediator in mice, increasing autoantibodies and decreasing lung function.
AIM 1. Lifestyle, Aging and Autoimmunity. Defining the MultiOme of Aging and Autoimmunity in the
context of a nutritional intervention is designed to identify a subgroup of firefighters who have a chronic
hyperinflammatory state, accelerated aging, and increased circulating autoantibodies that will be associated with
health and lung function metrics. We will then integrate the MultiOME using systems biology to optimize disease
specific models and identify mechanistic processes of WTC-Lung Injury.
AIM 2. Mechanistic pathways will be examined utilizing a mouse model to determine a cause-effect relationship
of WTC-PM exposure and high fat diet on aging and the exacerbation of hyperinflammatory responses (including
autoantibodies). We will use mice from a well-established, commercial model of aging with features of metabolic
syndrome, and expose them to WTC-PM. We will further study the effects of blocking a key anti-inflammatory
cytokine to determine adverse effects (lung function, structural lung and heart remodeing) of WTC-PM exposure.
The overall goal of this 2-year pilot is to begin to understand the mechanisms by which our nutritional intervention
improves health outcomes, focusing on the interactions between a diet high in fat, aging, diminished control of
inflammation and autoimmune antibodies. Our study outcomes will improve the overall understanding of how
WTC lung disease persists, enhance our ability to better manage adverse health effects, benefit the health/well-
being of WTC-exposed first-responders and falls squarely within the purview of the James Zadroga 9/11 Health
& Compensation Act. This pilot will help lay the ground work for targeted immune/lifestyle driven therapies.

Public health relevance
PROJECT NARRATIVE World Trade Center particulate matter (WTC-PM) exposure is associated with a greater risk of lung disease in patients with metabolic syndrome (MetSyn). We leverage our successful lifestyle-modulating FIREHOUSE randomized clinical trial, focused on mitigating MetSyn, and propose highly innovative studies: AIM 1 to determine the effects WTC-PM and the mitigating effects of our dietary intervention on the aging and autoantibody phenotypic profiles; AIM 2 will mirror our aging WTC cohort affected by a high prevalence of MetSyn, to determine its impact on accelerated aging and autoimmune markers in a murine MetSyn/WTC-PM model; and it will futher assess biologically plausible mediators and potential targets of inflammation that affect lung health. Our focus on aging, preclinical autoimmunity and metabolic activity will further our understanding of the adverse health effects of WTC-PM exposure, improve the health and well-being of WTC-exposed first- responders and falls within the purview of the James Zadroga 9/11 Health & Compensation Act.